The ASPIRES Study: Activating Cancer Survivors and their Primary Care Providers to Increase Colorectal Cancer Screening

Project Summary
Childhood cancer survivors treated with abdominal or pelvic radiotherapy (RT) are almost four times more
likely to develop colorectal cancer (CRC) compared to the general population with their elevated risk evident by
the age of 30 years with no plateau. Since earlier detection of precancerous lesions (i.e. adenomas) or CRC is
strongly associated with improved survival, screening with colonoscopy or multitarget stool DNA testing (mt-
sDNA) with a colonoscopy after a positive test is recommended starting at age 30. Unfortunately, the vast
majority of survivors at high-risk for CRC are not adherent to recommended screening. Magnifying this problem,
most childhood cancer survivors are no longer followed at a cancer center, are unaware of their risks and are
being followed by primary care providers (PCPs) who are not informed about the recommended follow-up care.
In order to improve adherence to CRC screening guidelines in high-risk childhood cancer survivors, we
propose the ASPIRES (Activating cancer Survivors and their Primary care providers to Increase coloREctal
cancer Screening) Study, which is the first known intervention to attempt to increase CRC screening rates in this
population using a remote digital mHealth intervention. This is a 3-arm randomized controlled trial to evaluate
the utility of patient activation with and without added PCP activation to increase CRC screening. We propose to
randomize 315 survivors, who are at least 30 years of age, with a history of abdominal or pelvic radiation for a
childhood cancer and without a history of CRC.
The primary outcome is obtaining CRC screening with colonoscopy or mt-sDNA during the 12-month
study period. We will determine the comparative effectiveness of (1) a mHealth patient activation intervention
and (2) patient activation plus PCP activation, compared to control. Secondary aims include (1) conducting a
multi-stakeholder mixed-methods Consolidated Framework for Implementation Research (CFIR)-informed
evaluation to understand patient, provider and system factors associated with uptake of the intervention, to
explore enablers and barriers to uptake of CRC screening, and to generate recommendations for future
adaptation, scalability and sustainability; (2) identify potential moderators and mediators of uptake of CRC
screening; and (2) estimate the cost-effectiveness of the intervention.
The proposed ASPIRES Study brings together a research team with necessary expertise and experience
in survivorship, CRC screening, dissemination and implementation, and mHealth intervention research with the
unique resource of the 31-institution Childhood Cancer Survivor Study (CCSS). Notably, the CCSS represents
the single largest cohort of survivors in the target population and the infrastructure to conduct the proposed
study. Results from this intervention will have important implications for patients at high-risk for CRC and we
expect that findings from this study will provide the evidence for implementation and dissemination of our CRC
screening interventions targeting these populations.

Public health relevance
PROJECT NARRATIVE Secondary to the therapies that cured childhood cancer survivors, most will develop a chronic disease early in life. For example, survivors treated with abdominal or pelvic radiation are at significantly elevated risk of colorectal cancer (CRC) at a young age. The proposed study aims to reduce the morbidity and mortality faced by these survivors by testing a remote intervention aimed at promoting early CRC screening and detection.